Shared Resource 11: Microscopy (MSR)

PROJECT SUMMARY – MICROSCOPY SHARED RESOURCE (MSR)
The MSR provides timely and high-quality services to support OSUCCC investigators with access to instrument,
technical advice and training support on a variety of sophisticated microscopy approaches. The MSR
instrumentation is provided in a centrally-organized resource and all the equipment is available to OSUCCC
membership with training. At the last review, the MSR was part of the Diagnostics Shared Resource Group,
which was rated as Outstanding with minor comments about leadership and usage that have been addressed.
During the current grant cycle, there was a significant investment in acquiring electron microscopy (cryogenic,
transmission and scanning electron microscopes) and confocal live cell imaging, including enhanced super-
resolution (SIM, STORM, TIRF) light microscopy capabilities funded through an NIH S10 equipment grant. The
Specific Aims of the MSR are to: 1) provide a means for OSUCCC research community to obtain publication
quality, higher resolution images of their cancer research for use in manuscripts and grant applications; 2)
provide training to investigators for independent use of the instruments following training; 3) provide education
and consultation opportunities to OSUCCC researchers for improved sample preparation, imaging techniques
and image analysis; and, as a Developing Aim to provide OSUCCC members access to cryo-electron microscopy
(cryo-EM). For this Developing Aim, the OSCUCC contributed to the purchase of two instruments with sub-
nanometer resolution of purified and cellular particles. During the five-year grant period, the MSR has supported
319 investigators (32% OSUCCC members), and provided 5,730 hours of service and 44,605 hours of
instrument time (33.3% of which was to OSUCCC members). The MSR contributed to 192 publications (32 > 10
impact factor) and 8 NCI grants (2 K22s, 1 P01, 1 P50, 8 R01s, and 1 U01). The MSR will support the microscopy
needs of all OSUCCC strategic priorities. Given the robust OSUCCC recruitment, demand for services and new
technologies will increase and capacity will be expanded. To align with immuno-oncology needs, the MSR will
be a regular member of the Immune Monitoring and Discovery Platform (IMDP), and two-photon microscopes
will be updated. Separately, the MSR is developing cryo-FIB capability for CET studies, and it will develop
correlative light and electron microscopy and real-time single molecule cellular imaging platforms in collaboration
with the GEdSR. Last, the MSR and GSR has been awarded a new grant to provide imaging capabilities that
supports cell enrichment and single cell sequencing. The MSR is supported by outstanding institutional
resources obtained by leveraging extensive partnerships with the OSUCCC, OSU Colleges, the OSU Office of
Research and grants from the State of Ohio, all totaling over $2M over the prior grant period. The annual budget
of the MSR is $697,706, yet the CCSG request is $82,192. As such, the MSR seeks only 11.8% budgetary
support from CCSG funds.